Expansion of Training and Program Components to Maintain Manufactured Food Regulatory Program Standards

PROJECT SUMMARY/ABSTRACT
The project “Expansion of Training and Program Components to Maintain Manufactured
Food Regulatory Program Standards” is designed to further advance the manufactured
food program in the State of Wyoming. Wyoming Department of Agriculture, Consumer
Health Services (WDA/CHS) has made great strides in improving the manufactured
food program statewide with the assistance of the Manufactured Food Regulatory
Program Standards (MFRPS). In October 2017 WDA/CHS was elated to learn that
after the 60 month Program Assessment Validation Audit (PAVA) the program was in
conformance with the MFRPS. WDA/CHS takes great pride in providing a quality
program for our inspection personnel and industry to be part of. This project will
address four (4) goals. The first goal is to adequately train our inspection personnel and
continue to meet MFPRS requirements. This training will equip inspection personnel
with the knowledge and ability to conduct quality inspections and further advance
WDA/CHS to be part of an Integrated Food Safety System. The training received will
also be used to provide education to industry. The second goal of this project is for
WDA/CHS to continue to show incredible growth in outreach to our clientele. Through
this project WDA/CHS will develop and produce a guide for Manufactured Food
processors addressing 21 CFR 117 and Food Safety Modernization Act (FSMA)
regulations and publish the Wyoming Food Safety Rule revision. This project includes
outreach to establishments required to have a Preventative Controls Qualified Individual
by providing FSPCA Preventative Controls for Human Food Training. The third goal of
this project is to adequately equip our inspection personnel to complete the inspections.
Additionally, WDA/CHS plans to expand our routine sampling program. All of the goals
listed above are incorporated into the final goal of this project, which is to advance the
manufactured food program and continue to conform to the MFRPS.

Public health relevance
PROJECT NARRATIVE The project “Expansion of Training and Program Components to Maintain Manufactured Food Regulatory Program Standards” is designed to further advance the manufactured food program in the State of Wyoming. Wyoming Department of Agriculture, Consumer Health Services intends to provide training to personnel and outreach education to industry to advance the manufactured food program. The ultimate outcome of this project is to expand training and program components to maintain manufactured food regulatory program standards in full conformance.